Development of Gold Nanocarriers for the Treatment ofRheumatoid Arthritis

Abstract
Rheumatoid arthritis (RA) is a disease with no cure that affects approximately 1% of the world's
population. It is characterized by inflammation, cartilage/bone destruction, and disorders of the
cardiovascular, pulmonary, and skeletal systems. Disease-modifying antirheumatic drugs such as
methotrexate (MTX) effectively manage the symptoms. Clinically, methotrexate is administered in a
high dose once a week due both to the rapid renal clearance and toxic side effects. Studies show that
patients undergoing treatment experience a twenty-six percent reduction in the number of inflamed
joints. While the MTX is highly effective, some patients experience articulations that do not respond to
systemic treatment with the drug. To address this issue, we will create nanocarriers to deliver MTX to
specific joints that do not respond well to its systemic delivery. The conjugation chemistry will be
developed to bind MTX to gold nanoparticles through environmentally responsive linkers, which will
serve as a slow-release nanocarrier system when injected into the targeted joints. Colloidal gold has
demonstrated anti-inflammatory properties when used to treat RA. The gold nanocarriers, along with
MTX and linkers sensitive to environmental cues like reactive oxygen species and the acidic conditions
of the synovial fluid, are expected to have a synergistic and pronounced effect in reducing inflammation.
The acid and reactive oxygen species release mechanisms of the nanocarriers will be studied along
with their cytotoxicity. Next, the efficacy of the gold nanocarriers will be determined by analyzing the
levels of reactive oxygen species, tumor necrosis factor (TNF-), interleukin 6 (IL-6) and interleukin 1
(IL-1) produced by RAW 264.7 macrophages upon in vitro inflammatory stimulation. RAW 264.7
macrophages are used as a model cell line to study inflammation responses of other gold nanoparticle
formulations. It is expected that the inflammatory variables evaluated will be reduced in vitro. This
research will lay the groundwork for testing in animal models and may eventually lead to changes in
the administration of methotrexate to patients.

Public health relevance
Project Narrative Patients suffering from rheumatoid arthritis often require intra-articular injections to effectively manage this debilitating disease. The gold nanocarriers are expected to release their drug payload in response to environmental cues, which would provide continuous palliative treatment. This would reduce disability and improve the quality of life for patients.